Low-Cost Amperometric Ozone Monitor for Communities Affected by Wildfires

PROJECT SUMMARY/ABSTRACT
Low-Cost Amperometric Ozone Monitor for Communities Affected by Wildfires
The rising frequency and severity of wildfires (forest fires, biomass fuel fires, etc.) in the United States is an
important environmental public health issue. Smoke produced during a wildfire travels far downwind, exposing
roughly 2/3 of Americans to pollutants detrimental to ambient air quality. A vast majority of the medical and
scientific effort is focused on the populations’ exposure to fine particulate matter produced during these fires.
However, ozone from wildfires can lead to many pulmonary health conditions and, unlike particulate matter,
cannot be mitigated using HEPA filters or N95 masks. Despite the negative health effects there are few tools
available for monitoring ambient ozone concentrations during these natural disasters. Current detection
equipment is expensive, prone to interference, and sacrifices accuracy when made portable. Consequently,
most communities have little information regarding their exposure and health officials are unable to assess the
health impact of ozone produced from wildfires.
Recent advancements in electrochemical gas sensor technology make them an appealing option to monitor
ambient air pollutants. Developments in screen printed electrode fabrication and research into non-aqueous
electrolytes have resulted in low-cost devices with performance comparable to bench top instruments. Interest
in room temperature ionic liquids (RTILs) as an alternative electrolyte media has made long-term remote gas
sensing more practical. Unlike aqueous electrolytes, RTILs have negligible vapor pressures and high stability
so they do not dry out or take part in electrochemical reactions. This program will develop a thick-film
electrochemical sensor utilizing RTILs for autonomous monitoring of ozone in communities affected by
wildfires. Leveraging Giner’s electrochemical sensor experience a low-cost ozone detector will be made widely
accessible to the public for the first time. Giner’s fully developed monitor will have a limit of detection (LOD) of
10 ppb, linear range of 10-500 ppb, and prevent interference from other common wildfire gases. A
corresponding portable instrument will be developed to include electronics, battery power, and wireless data
communication for use by health officials, researchers, and citizens within affected communities.

Public health relevance
PROJECT NARRATIVE The increasing frequency of wildfires exposes significant portions of the U.S. public to harmful levels of ozone gas responsible for many acute and chronic health conditions. Commercially available equipment for its detection is expensive and, consequently, many rural communities in high-risk areas are unable to assess their exposure. Giner’s low-cost handheld ozone detector would enable widespread monitoring of ambient ozone concentrations, improving exposure awareness and informing public health policy.